Data Integration and Sharing Core

PROJECT SUMMARY/ABSTRACT
For this U19 Program Project, we will establish a Data Integration and Sharing (DIS) Core to process and analyze
the large amount of data that will be generated by its four research projects. This U19 proposes an integrated
study to test a new approach for developing therapies for age-related diseases. Rather than focusing on
individual diseases, we explore genetic differences between successfully aged, healthy centenarians and control
individuals with no family history of extreme longevity. Our long-term goal is to use gene variants found enriched
in the centenarian genome as potential targets for developing drugs that prevent, delay onset and progression,
and possibly even revert many of the multiple age-related diseases. The overall objective of the DIS core is to
provide a computational and statistical platform to the project investigators for analyzing and sharing their data
in concert, thereby achieving the aims of the U19 project grant. The central hypothesis of this U19 is that
centenarians harbor protective genotypes of rare variants in conserved aging pathways, which can be used to
identify novel drug targets as the basis for subsequent development of therapeutics against multiple age-related
diseases and to ultimately increase human healthspan. This hypothesis has been formulated based on a large
body of data already produced in this U19. The rationale for a dedicated core to that purpose is that a
consolidated facility is needed to manage the large amount of data on the whole genome level generated by
each of four highly integrated projects of this U19. This DIS Core will be established to achieve three specific
aims: 1) To assist projects in processing and analyzing the data that they generate; 2) To integrate project data
at the systems level and identify genetic network of pro-longevity drug targets; 3) To develop a web portal to
warehouse and share data generated by the projects. The function of the DIS Core is significant, because it will
be set up to meet the challenge posed by the high volume of data that need to be generated, examined at
multiple levels by a variety of approaches, integrated to develop the models for lifespan control, and shared
among project investigators and the scientific community at large.

Public health relevance
PROJECT NARRATIVE The proposed data core is relevant to public health because a web data portal and novel computational methods will be developed to tackle the genetic bases and molecular mechanisms of human aging related to common human diseases and its targets for developing anti-aging therapies. The web data portal will also be used to disseminate the data to the larger research community. The proposed research is directly relevant to the NIA mission in that it pertains to developing fundamental knowledge that will help reduce the burdens of human disabilities associated with advanced age.